Mechanism and Uses of Transmembrane Helix Insertion by Soluble Peptides

PROJECT SUMMARY/ABSTRACT

The understanding we now have of the pHLIPs (pH-­Low Insertion Peptides) enables the design of novel, pH-­
sensitive targeting agents that use the acidity of tumor cell surfaces as a biomarker. The work supported by
this grant has already yielded a new diagnostic nuclear imaging agent (PET-­pHLIP) and a new fluorescent
imaging agent for image-­guided surgical interventions (ICG-­pHLIP), which are advancing to clinical trials at
Memorial Sloan Kettering Cancer Center in 2019.
The primary focus of this continuation is to enable targeted intracellular delivery of polar and moderately
hydrophobic therapeutic molecules. We propose a systematic approach using representative cargoes from 3
classes of therapeutic molecules that possess different physical, chemical and functional properties: i) a
moderately hydrophobic, sparingly cell-­permeable, small drug molecule: mertansine;; ii) a moderately polar,
cell-­impermeable, cyclic, rigid, larger drug: amanitin;; and iii) a large, polar, cell-­impermeable drug:

calicheamicin. Each of these drugs is currently under development or in use as an antibody-­drug conjugate
warhead, but there are important limitations to the antibody approaches, including limited biomarker
availability, resistance selection, a narrow therapeutic window and limited delivery, often with < 1% of a
construct reaching the tumor. Our approach is based on targeting tumor acidity, especially cancer cell surface
pH that is a general parameter within and among different tumors, and independent of tumor perfusion.
We propose to explore variation of pHLIP sequences, introduce pHLIP-­cycles and exploit pHLIP-­bundles for
delivery of these therapeutic cargoes. The pHLIP-­cargo constructs will be tested for insertion stability and
kinetics, using biophysical methods and computational modelling. Activity will be evaluated in cells, and
promising constructs will be assessed in vivo. We will accumulate a parameter database of pHLIP-­cargo
properties and employ modern bioinformatics algorithms to analyze the entire data set to reveal major design
principles.
By studies of these therapeutic agents with pHLIPs, we hope to find principles for targeted delivery of a range
of other compounds. Should we be successful, the limitations of antibody drug conjugates for therapy will be
overcome, and greater understanding of the membrane barrier will also be in hand. Our expectation is to have
a candidate for the treatment of bladder cancer as the practical outcome of this grant renewal.

Public health relevance
PROJECT NARRATIVE Our work on the pH- triggered insertion of transmembrane helices using pHLIPs (pH- Low Insertion Peptides) has given two pHLIP- based imaging agents now entering clinical trials and has led to new insights about the basic science of peptide insertion into membranes in terms of structure, energetics and kinetics. As we learn more about the principles, we are able to design better versions of peptides for specific clinical applications. The primary focus of this continuation is to enable targeted intracellular delivery of polar and moderately hydrophobic therapeutic molecules, maximizing their therapeutic effects while reducing side effects.